CRCNS Research Proposal: Collaborative Research: US-German Collaboration toward a biophysically principled network model of transcranial magnetic stimulation (TMS)

Neurological and psychiatric diseases are a major burden on society and new treatment options are
strongly needed. One strategic goal of NIBIB is to develop innovative biomedical technologies that
integrate engineering and life sciences to improve health. TMS is a non-invasive neuromodulation
technique that can directly interfere with brain activity. TMS is FDA-approved for a range of brain
disorders, however, shows mixed efficacy. Thus, improved stimulation protocols would have a major
impact in providing better treatments for brain diseases associated with alterations in cortical excitability.
Here, we propose to develop a multiscale network model of TMS that will combine electric field
simulations with neuron models and molecular simulations of intracellular calcium.

Public health relevance
This project is a first important step towards biology-driven, computer-assisted personalized rTMS therapies to promote beneficial neural plasticity. Moreover, our molecular approach provides the perspective in testing synergistic effects of pharmacological interventions and rTMS-based therapies, which may be instrumental in informing future clinical trials. Our computational approaches will generate new tools for predicting the effects of TMS and will hence greatly improve our understanding of selected stimulation parameters.